Optimized Sodium MR Imaging at Clinical Field Strength to Study in vivo Sodium Signal in Mild Traumatic Brain Injury

PROJECT SUMMARY
This proposal aims to use innovative advances in sodium MRI (NaMRI) and proton (1H) diffusion MRI to identify
imaging biomarkers of disease in patients with Mild Traumatic Brain Injury (MTBI). NaMRI provides unique in
vivo ionic information about the brain, though has historically been plagued by low signal-to-noise ratio (SNR),
limiting its utility in studying clinical populations. However, recent technological advances proposed here allow
translation to clinical groups such as patients with MTBI. MTBI is a major public health problem yet the underlying
pathophysiology remains a mystery and ionic imbalance including sodium dysregulation has been implicated in
the disease in cell and animal experiments as well as preliminary studies in human subjects. Quantifying brain
sodium in MTBI and finding NaMRI biomarkers for disease is particularly exciting as this could shed light on the
mechanism of injury in MTBI and open the door to the development of new treatment pathways which are badly
needed. Furthermore, there are promising results from cellular and animal models of MTBI using selective
sodium channel blockade that mitigate damage relating to injury, suggesting sodium plays a central but as yet
unexplored role in the pathophysiology of MTBI.
Our team’s combined strengths in innovative and cutting-edge NaMRI methods, diffusion microstructure imaging,
and MTBI will allow us to meet the goals of this project. We propose to leverage technical advances that make
NaMRI clinically feasible at 3.0T, including work from our group in multinuclear coil design, image acquisition,
image reconstruction and data analysis. The work specifically seeks to quantify NaMRI signal to 1) characterize
changes after injury, 2) explore the link between known white matter compromise and altered brain sodium in
conjunction with advanced diffusion MRI and 3) determine if sodium mediates the relationship between
microstructural changes and clinical symptoms. Identifying surrogate imaging biomarkers to better quantify injury
and recovery will allow development of objective return-to-activities recommendations, address the need to
develop methods to predict risk for prolonged symptoms, and point to new pathways for therapy.

Public health relevance
PROJECT NARRATIVE Sodium MRI (NaMRI) has been challenging due to inherently low signal-to-noise and resolution but holds much promise in the study of neurological diseases including Mild Traumatic Brain Injury (MTBI) where the underlying mechanisms are still unclear and effective therapies are badly needed. Here we propose innovative multinuclear imaging techniques including advances in coil design, acquisition optimization, image reconstruction as well as cutting-edge MRI microstructure modeling to optimally quantify in vivo NaMRI signal in MTBI. We will study the relationship between NaMRI, microstructural injury and clinical outcome at 3.0 Tesla, translating promising evidence from cell and animal studies to a clinical MTBI population in the search for effective noninvasive surrogate imaging markers for injury.